Molecular Chaperone Recognition of CFTR Stability

1 PROJECT SUMMARY
2 Cystic fibrosis (CF) is a lethal genetic lung disease caused by mutations in the Cystic Fibrosis
3 Transmembrane Conductance Regulator (CFTR), an epithelial anion channel protein. The most common patient
4 mutation, deletion of phenylalanine 508 (ΔF508) and many of over 1000 mutations destabilize CFTR. Unstable
5 ΔF508 is recognized by molecular chaperones as unfolded. Chaperone binding to mutant CFTR eventually
6 results in pre-mature degradation leading to CF. Precisely how molecular chaperones recognize ΔF508 CFTR
7 as unfolded is unclear. Previous in vitro studies characterized chaperone binding hotspots in CFTR peptides and
8 individual domains; however, the chaperone binding hotspots that ΔF508 unfolds and exposes in the cell remains
9 unknown. We hypothesize domain and sub-domain level ΔF508 unfolding exposes chaperone binding hotspots
10 recognized by molecular chaperones. Additionally, we hypothesize stabilizing ΔF508 CFTR with FDA approved
11 CF therapies will restore domain and sub-domain level chaperone recognition towards WT CFTR. In aim I, we
12 propose simulating full-length WT and ΔF508 CFTR structures in silico to determine how ΔF508 deviates from
13 normal WT structure. We can build ΔF508 CFTR models in Rosetta, dock CF drugs to the structures, and
14 benchmark methods for sampling CFTR conformational space by comparing simulations results to published
15 experimental data. In aim II, we propose site-specific non-canonical amino acid incorporation of photochemical
16 crosslinkers to covalently capture molecular chaperone binding to CFTR domains and sub-domains in live cells.
17 We can identify and quantify site-specific CFTR interactors by affinity-purification mass spectrometry with
18 Tandem Mass Tag labeling. Furthermore, we will again stabilize ΔF508 CFTR with CF drugs to examine how
19 small molecule binding impacts molecular chaperone binding. Studying the relationship between drug binding
20 and chaperone recognition is important because the only targeted treatment for CF involved stabilizing ΔF508
21 CFTR with small molecules called pharmacological chaperones. However, pharmacological chaperones are
22 discovered through expensive phenotypic screens and their molecular mechanisms remain unclear. We seek to
23 distinguish whether pharmacological chaperones change molecular chaperone recognition in the domain of
24 binding or nearby domains through allosteric effects. Other misfolding diseases, such as cardiac arrythmia Long
25 QT Syndrome, are caused by mutations in similar membrane proteins, but drug treatments lay out of reach due
26 to lack of assays for screening. Thus, we developed methods to evaluate pharmacological chaperones and their
27 contributions to CFTR structural stability. Our novel approach will elucidate the interplay between unstable
28 mutants, molecular chaperone recognition, and pharmacological chaperone rescue by leveraging and integrating
29 data from computational structural biology and proteomics. This will pave the way for structure-based and
30 computer aided drug design of pharmacological chaperones.
31
32

Public health relevance
PROJECT NARRATIVE Cystic Fibrosis is a lung and multi-organ disease caused by over 1000 identified patient mutations that destabilize the Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) protein causing it to become degraded by the cell. How the cell recognizes mutant CFTR compared to normal wild type (WT) CFTR remains poorly understood; but understanding would inform translatable research on individual differences in CFTR mutants. This proposal outlines a cross-disciplinary computational structural biology and proteomics approach for identifying where CFTR mutations are recognized as unfolded and understanding how FDA approved drugs stabilize CFTR towards the goal of improving Cystic Fibrosis therapies.